Biorepository and Pathology

The TCI Biorepository and Pathology Shared Resource (BPSR) integrates biorepository, histology, immunostaining, and molecular services in support of basic, clinical, epidemiologic, and translational cancer research throughout the TCI community. Biopsy and surgical specimens are processed, banked, and distributed to investigators as fresh, frozen, fixed, or procured according to investigator specifications. The BPSR hosts a suite of advanced pathology services including diverse staining, imaging, and quantitative digital image analyses; along with macromolecule extraction for subsequent investigations. Liquid biospecimen processing and management support TCI research programs and clinical trials. Finally, the BPSR is a multi-dimensional group providing consultation, education, technical support, and training for basic science, translational, and clinical cancer researchers across the Mount Sinai Health System. The Specific Aims of this Shared Resource are to: (1) Manage tissue procurement, processing, banking, and distribution services; (2) Provide staining, molecular characterization, and analyses of tissues.